Vaccine Immunology Program

The Vaccine Immunology Program is responsible for the end point analyses of clinical vaccine, therapeutic and prevention trials carried out by the Vaccine Research Center and collaborates with intramural and extramural investigators. In addition, the VIP investigates basic B and T cell immunobiology to elucidate the mechanisms that inform the discovery and development of vaccines for public health, including HIV, Influenza, Ebola, Zika, Malaria, TB, SARS-CoV-2 plus other emerging and re-emerging infectious diseases, and develops sophisticated analyses that supports in-depth investigation of clinical vaccine trials, including highly qualified clinical assays for use in IND submissions and product licensure purposes.